The non-invasive early detection of endometriosis

ABSTRACT
Endometriosis is a debilitating disease involving the growth of endometrial glands and stroma outside the uterus.
The primary symptoms are pelvic pain and infertility. Nearly half of affected women have chronic pelvic pain,
and in 70% of those, the pain occurs during menstruation. Pain with sex (“dyspareunia”) and infertility occur in
close to half of women affected by endometriosis. Less common symptoms include urinary or bowel symptoms.
About 25% of women have no symptoms. Endometriosis can have both social and psychological effects.
Currently, definitive diagnosis is achieved by surgical biopsy. Because of the invasive nature of this method, the
diagnosis and treatment of endometriosis is considerably delayed, with average time from symptom onset to
diagnosis being 10 years. The consequence of this significant delay is prolonged and progressive pain, a risk of
infertility and considerable social/economic impact.
The purpose of this study is to develop non-invasive screening methods for the early detection of endometriosis.
Specifically, we will target DNA methylation signatures carried by circulating fragments of extracellular DNA,
referred to herein as cell-free DNA (cfDNA). These fragments, which are detected in a variety of fluid reservoirs
including blood plasma, convey epigenomic information both about their cell type of origin and its pathological
state. Our over-arching hypothesis is that altered DNA methylation signatures in the uterine tissue of
endometriosis patients are detectable via analysis of plasma-derived cfDNA. In this study we will build a
foundation of preliminary data towards the development of methods for the early non-invasive detection of
endometriosis.

Public health relevance
PROJECT NARRATIVE: Endometriosis is a debilitating disease involving the growth of uterine tissue outside the uterus. The over-arching goals of this study are to develop a blood test for the non-invasive detection of endometriosis. The proposed study will improve our understanding of the biology of endometriosis and lead to the development of new diagnostic/screening tools to help us identify women at high risk of endometriosis for whom an intervention may be tested and for whom intervention is most critically needed.